Collaborative Research Training in Thrombosis and Inflammation

This new T32 program will prepare postdoctoral trainees for collaborative research careers in
two inter-related topics: thrombosis and inflammation. There is increasing evidence of a direct
relationship between thrombosis and inflammation in numerous human diseases. As examples,
inflammation contributes to the pathogenesis of thrombotic disorders such as stroke and
coronary artery disease, while thrombosis influences disease severity in conditions associated
with inflammation including sepsis, autoimmune diseases and cancer. While thrombosis and
inflammation frequently coexist, to our knowledge, this will be the only T32 program in the nation
with a primary focus on both processes. The Center for Translational Research on Inflammatory
Diseases (CTRID) at Michael E. DeBakey VA Medical Center and the Division of Thrombosis
Research at Baylor College of Medicine will sponsor this collaborative training program with
rigorous research opportunities and close mentoring by faculty. The group of 17 faculty mentors
includes 14 NIH-funded investigators and 6 VA Merit-funded investigators; 12 of the mentors are
physician-scientists and the balance non-physician scientists. The major strengths of our
program include: 1) a cohesive and highly collaborative group of successful mentors with
research expertise in relevant topics for our program, including platelets, neutrophils,
microvascular thrombosis, stroke, cancer, sepsis, inflammatory conditions in kidney, lung, and
bone, among others; 2) a unique combined curriculum with shared didactic and clinically-
oriented training for physician and non-physician trainees; and 3) it is based in a thriving
research center committed to mentoring, including a weekly seminar series that consists of >
60% speakers with scientific interests aligned with the themes of this T32. In addition to training
physician-scientists in biomedical research, PhD scientists will be trained in translational
medicine offering a direct interaction with patients with clinical conditions related to the focus of
this T32. PhD trainees will be paired with physician trainees during these clinical practicums; this
collaborative aspect of the program will teach PhD postdoctoral fellows the importance and
benefit of conducting research in collaboration with physician-scientists and vice-versa. The
program consists of 2-3 years of research training, enriched by didactic courses, an outstanding
seminar series and a vibrant scientific environment. Successful implementation of this T32 in
Thrombosis and Inflammation will pave the way for new biological insights and novel ways of
prevention and treatment of thrombotic-inflammatory disorders by educating future physician-
and non-physician scientists for collaborative research careers in thrombosis and inflammation.

Public health relevance
This is an institutional training program to train physician and non-physician (PhD) scientists in a collaborative manner to become research leaders in two closely related areas: abnormal formation of blood clots (thrombosis) and the body's response to injury or infection (inflammation). Thrombosis and inflammation are present in a broad range of severe human diseases in need of greater research, ultimately leading to advances in health.